NHLBI Animal Program Division

The Animal Program Division provides technical and collaborative research support to these investigators within NHLBI. Robert S Adelstein, MD (GDBC, DIR, NHLBI) Marcelo Amar, MD (NHLBI) Stasia A Anderson, BS, PhD (AMRI, GDBC, DIR, NHLBI) Joshua Anzinger (TMB, DIR, NHLBI) Andrew E. Arai, MD (LCE, TMB, DIR, NHLBI) Manfred Boehm, MD (TMB, DIR, NHLBI) Maurice Benjamin Burg, MD (LKEM, CBPC, DIR, NHLBI) Jichun Chen, PhD (HB, DIR, NHLBI) Richard W Childs, MD (HB, DIR, NHLBI) Jay H Chung, MD,PhD (LBG, GDBC, DIR, NHLBI) Robert E Donahue, VMD, MS (HB, DIR, NHLBI) Cynthia E. Dunbar, MD (HB, DIR, NHLBI) Neal D Epstein, MD (GDBC, DIR, NHLBI) Toren Finkel, MD,PhD (TMB, DIR, NHLBI) Stephanie French, PhD (LCE,NHLBI) Herbert Geller, PhD (OSD, NHLBI) Ahmed Gharib, MD (OSD, NHLBI) Lois Greene, PhD (LCB, CBPC, DIR, NHLBI) John A. Hammer, III, PhD (LCB, CBPC, DIR, NHLBI) Keith A Horvath (OCD, DIR, NHLBI) Paul M Hwang, MD, PhD (TMB, DIR, NHLBI) Gregory J Kato, MD (TMB, DIR, NHLBI) Geumsoo Kim, PhD (LB, BBC, DIR, NHLBI) Mark A Knepper, PhD, MD (LKEM, CBPC, DIR, NHLBI) Robert M. Kotin, PhD (LBG, GDBC, DIR, NHLBI) Kenneth L Kramer, PhD (GDBC, DIR, NHLBI) Robert J Lederman, MD (TMB, DIR, NHLBI) Warren J Leonard, MD (LMI, IC, DIR, NHLBI) Rodney L. Levine, MD, PhD (LB, BBC, DIR, NHLBI) Stewart J Levine, MD (PVMB, DIR, NHLBI) Chengyu Liu, PhD (GDBC, DIR, NHLBI) Cecilia W. Lo, PhD (GDBC, DIR, NHLBI) Andreas Erik Lennart Lundqvist (HB, DIR, NHLBI) Vincent Manganiello, M.D., Ph.D. (TMB, DIR, NHLBI) Muhammad M Mohiuddin, MD (CSRP, OCD, DIR, NHLBI) Joel Moss, MD, PhD (TMB, DIR, NHLBI) Yosuke Mukoyama (LDB, GDBC, DIR, NHLBI) Elizabeth Murphy, PhD (TMB, DIR, NHLBI) Elizabeth G. Nabel, MD (OD, NHLBI) Donald Orlic, (TMB, DIR, NHLBI) Vinay M Pai, PhD (TMB, DIR, NHLBI) Jeremy Pantin, MD (HB, DIR, NHLBI) Lance Pohl, PharmD,PhD (LMI, IC, DIR, NHLBI) Alan T Remaley, MD,PhD (PVMB, DIR, NHLBI) Alessandra Cecilia Rovescalli, PhD (LBG, GDBC, DIR, NHLBI) Michael Neil Sack, MD (TMB, DIR, NHLBI) Brian Schulte, MD (HB, DIR, NHLBI) James R. Sellers, PhD (LMP, CBPC, DIR, NHLBI) Robert D. Shamburek, MD (TMB, DIR, NHLBI) Clare M Waterman (CBPC, DIR, NHLBI) Adrian Wiestner, MD (HB, DIR, NHLBI) Han Wen, PhD (LCE, CBPC, DIR, NHLBI) Keji Zhao, PhD (LMI, IC, DIR, NHLBI)